Investigator Development Core

PROJECT ABSTRACT/SUMMARY – Investigator Development Core
There is a critical need to support early-stage investigators (ESIs) researching solutions to well-documented
disparities in cardiovascular disease (CVD) and related chronic conditions (RCC) that disproportionately
burden communities identified as Black, Indigenous and people of color (BIPOC). This work requires direct
participation from the groups most affected, who are traditionally underrepresented in science and medicine
(URSM); unfortunately, URSM investigators often lack institutional resources and structural supports that are
critical for success. To address these needs, the Investigator Development (ID) Core of the proposed P50
Center for Chronic Disease Reduction and Equity promotion Across Minnesota (C2DREAM) has two primary
goals: (1) Administer a pilot grant program that supports and empowers awardees to conduct high-impact
research on CVD and RCC among BIPOC communities across Minnesota. (2) Prepare the next generation of
investigators to conduct multi-level, multi-disciplinary interventional research to address racism and other
social and structural determinants of CVD and RCC disparities. Both goals are undergirded by a focus on
increasing the diversity of the scientific workforce. We have 3 Specific Aims. Aim 1: Facilitate the development
and successful conduct of innovative pilot projects (minimum of 30 projects over 5 years) led by a diverse
group of ESIs aimed at addressing CVD and RCC disparities in Minnesota’s BIPOC communities. Projects will
target one or more of C2DREAM’s priority health disparities populations in Minnesota and CVD or RCC
disparities, be aligned with the C2DREAM conceptual framework, use a multi-level, multi-domain approach
consistent with the NIMHD framework, and include a mentoring plan for the ESI and a plan for community
engagement. Aim 2: Design and launch a robust series of workshops, seminars, networking opportunities and
research resources, called Support and TrAining for Research Success (STARS), to promote preparation,
productivity, and advancement of ESIs. Aim 3: Evaluate the effectiveness of the ID Core on success of pilot
projects and career development of ESIs. We propose innovative, multifaceted approaches to accomplish our
Aims. The pilot grant program includes a training option (Pilot Incubator Intensive series) to improve unfunded
applications and keep promising investigators in the pipeline. We have engaged >130 faculty from across our
partnering institutions to serve as faculty affiliates for the Center who are committed to serving as mentors and
pilot application reviewers. We will conduct participatory workshops and intensive one-on-one coaching with
ESIs as they develop peer-reviewed manuscripts and future grant proposals, provide networking opportunities
and a suite of resources to support ESIs. The ID Core will have impact by creating a rigorous infrastructure
designed to promote success of ESIs (including postdoctoral fellows, ESIs and community researchers from
other C2DREAM-aligned programs across the region) and improve recruitment and retention of URSM
investigators in the scientific workforce addressing chronic disease disparities.